Nanogel Electrophoresis for Micro and Nanoscale Analyses of Glycosylation

Glycosylation, and in particular sialylation, is fundamental to molecular structure, function, stability, and
signaling. Although glycosylation is a critical biomarker and drug target to improve human health, it is a
challenging post-translational modification to study. This is because of the difficulty in distinguishing
structurally similar monomeric residues which are connected to form linkage and positional isomers.
Moreover, these structures are labile, easily degraded, and reference standards are costly and of limited
availability. Research in the Holland lab addresses these challenges to glycan research through
miniaturized native enzymatic reactions that are integrated in real-time with separation-based assays.
Biocompatible nanogels are used to advance nanoscale reactions by enabling new separation modalities
which are critical to evaluating and harnessing enzyme activity. These self-assembled nanogels are
thermally reversible separation materials that maintain the biological function of complex biomolecules
and provide a means to create and embed multifunctional assays in capillary electrophoresis. Nanogel
separations create nanoliter reaction zones to interrogate biomolecules in seconds. The 5-year program
outlined in this proposal centers on 3 fundamental goals.
Goal 1 generates fast, low-volume assays that quantify enzyme activity in complex systems with optical
detection and mass spectrometry under physiological conditions. Monovalent and multivalent
interactions that model viral infections are characterized in-capillary at the picogram level.
Goal 2 introduces new serial nanoscale processing of glycoproteins in microscale channels by integrating
high efficiency nanogel electrophoresis with enzymes and lectins. Heterogeneous glycoprotein ligands
are systematically sorted to report the structural distribution of glycans prior to mass spectrometry.
Goal 3 creates a glycan foundry; thereby, providing a tool to customize standard synthesis through an
automated microscale enzyme-based remodeling. An automated capillary electrophoresis method is
adapted to trimming and rebuilding custom glycan substrates and ligands within minutes.
The overall vision of the research program is to develop enabling biotechnology tools to advance
fundamental studies of glycosylation. With new microchannel separations the nanoliter reaction zones
can be used to elucidate biomolecular interactions that lead to infection and disease, interrogate glycan
structures with unprecedented accuracy, and provide a new platform to researchers to customize the
synthesis of glycoforms in-house to advance research in human health related to glycobiology.

Public health relevance
This proposal addresses the compelling need for new tools to study the relationship between human health and glycosylated molecules that play a role in disease. New technology which overcomes current limitations in the field will be established to improve research in the evaluation of glycosylation.